Training in HIV Translational Research

ABSTRACT
Investment in the training of young scientists to focus on key HIV research areas is critical to achieve our
ambitious goal of controlling the HIV epidemic worldwide. The pace of progress has always been rapid in the
field of HIV, with new findings and challenges dramatically altering the research agenda, as illustrated by the
impact of COVID-19 pandemic on persons with HIV. Decades, not years, of work are ahead of us. Our program
has successfully trained physician researchers now serving in leadership and faculty positions in academic and
public health institutions around the U.S. In this renewal, we propose rigorous training for physicians in high-
impact HIV research areas including HIV cure, biomedical prevention, novel treatments, co-infections (TB, STIs)
with a cross cutting focus of disparities. The program is co-directed by two physician scientists (Havlir and Deeks)
who have extensive and complementary experience across the spectrum of translational research via laboratory-
based, clinical, implementation and population level research in HIV and its complications in the domestic and
international setting. We are launching new approaches and programs to support our pipeline of URM
investigators to join the HIV research workforce. At completion of the program, we expect our graduates to have
achieved the following: (1) to have a track record of publications; (2) to be well on their way to becoming
productive, independent researchers at an academic or other public or private research entity; (3) to have
secured K-level funding, VA career development awards, R21, or R01 funding the scholar stays in academia.
We strive to train leading HIV patient-oriented and translational physician scientists and for these leaders to
consist of women, men, and persons of diverse racial/ethnic and socioeconomic backgrounds

Public health relevance
PROJECT NARRATIVE HIV continues to be a major cause of death and suffering worldwide. Our program supports training of early career stage investigators to become independent, patient-based and translational scientists addressing the highest impact research questions in HIV that are designed to reach affected populations. Building on the successful outcomes of our prior training program, we aim to train the next generation of researchers in HIV biomedical prevention, novel treatments and cure research.